Sibling Assessment in Prevention of Pediatric NAFLD in Hispanic Children

Abstract
Nonalcoholic fatty liver disease (NAFLD) is an obesity-associated liver disease that affects an
estimated 7 million children in the United States. It is the most common reason for liver
transplantation in adults and increases long term risk of diabetes and cardiovascular disease.
NAFLD disproportionately affects Hispanic children and is an exceptionally important health
disparity. The original R01 study focuses on use of a low sugar diet intervention for prevention of
NAFLD in pre-pubertal children. The proposed administrative supplement studies are designed
to expand the project to siblings of the primary participant and to add assessment of response of
diabetes risk factors to the intervention. The findings will have sustained and significant
implications for health promotion in Hispanic children, reduce health disparities, and inform
future prevention efforts for children at increased risk of NAFLD and diabetes.

Public health relevance
Project Narrative: Nonalcoholic fatty liver disease (NAFLD) is the most common disease in children and is closely associated with insulin resistance and eventual type 2 diabetes. This supplement project will enhance the studies of the R01 entitled Prevention of Pediatric NAFLD in Hispanic Children by expanding the recruitment group to include siblings of children in the prevention interventional study and expanding the focus to include predictors of diabetes in the children undergoing the intervention.